Lasso Peptide Discovery

ABSTRACT/PROJECT SUMMARY
Lasso peptides are a class of ribosomally synthesized and post-translationally modified peptide (RiPP)
natural products categorized by their unique threaded rotaxane structure. Genome mining studies from my
group and others have revealed that these peptides are found in a wide variety of different prokaryotic
organisms in environments as varied as the human gut and the deep sea. This proposal will leverage the
latest generation of our genome mining software to catalog all known lasso peptides in sequenced genomes.
We will continuously update this list and make it available to the natural products community. Leveraging our
unique insights into lasso peptide activity, we will prioritize several peptides for further structural and functional
studies. In particular, we plan to study lasso peptides predicted to have novel antimicrobial activities against
pathogens. Finally, we will also leverage our genome mining work to carry out an in depth biochemical and
structural study of lasso peptide biosynthesis.

Public health relevance
PROJECT RELEVANCE The proposed project focuses on the prediction and isolation of novel lasso peptides, a class of bioactive natural product. The project has a specific focus on identifying and producing lasso peptides with antimicrobial activity. This research will contribute to the arsenal of antibiotics available to treat infectious disease.